Statistical and Data Coordinating Center (SDCC) for Clinical Research in Infectious Diseases: Mpox Clinical Research Activities

The Statistical and Data Coordinating Center provides comprehensive statistical support, data management and analysis activities for DMID-sponsored clinical trials. This includes internet-based electronic data collection, data management, data quality control and a specimen tracking system. In addition, the contractor provides consultation on statistics, study design, appropriate control groups, sample size, power calculations, randomization, stratification, and analysis.